Multi-tissue type condensations for trachea tissue regeneration via individual cell bioprinting

Abstract
As a result of prolonged intubation, tracheostomy, external trauma, penetrating fragment projectiles, gunshot
wounds and improvised explosive devices during combat, and benign or malignant tumors, many soldiers and
veterans in the US military suffer from severe trachea stenosis or damage that can cause complete airway failure,
Since there is no successful long-term treatment for long-segment tracheal stenosis or damage, tissue
engineering strategies have been explored to develop neotracheas using different combinations of biomaterials
and cell sources. However, biomaterial scaffold-based approaches often interfere with critical cell-cell
interactions, cell proliferation and new extracellular matrix production that are important during the formation of
functional trachea tissue. A functional replacement trachea must retain (1) radial rigidity to prevent restenosis,
(2) anastomose with host vasculature to adequately provide nutrients to the implant, and (3) contain respiratory
epithelium to provide a protective mucosal layer. Combining three-dimensional (3D) bioprinting technologies with
scaffold-free tissue engineering principles presents a powerful platform for engineering a multi-tissue functional
trachea, and would circumvent the aforementioned limitations of scaffold-based approaches. This proposal aims
to leverage the benefits of our recently developed individual cell-only 3D bioprinting technology, which allows for
printing of complex and high-resolution cell condensation-based tissue constructs to engineer functional
tracheas. We plan to print scaffold-free, multi-tissue neotracheas using multiple discrete individual cell-only
bioinks for spatially distinct differentiation of tissue types driven by spatially controlled presentation of tissue-
specific growth factors. Construct self-assembly will be driven by the condensation of autologously sourced
human mesenchymal stem cells (hMSCs) for cartilaginous tissue and autologous endothelial progenitor cells
and hMSCs for prevascular tissue, with autologous human bronchial epithelial cells applied to line the lumen of
the neotrachea. Specifically, this proposal aims to (1) examine the role of the physical properties of the microgel
support slurry on cell-only bioink printing, condensation formation/maintenance, and chondrogenesis of the 3D
bioprinted structures, (2) 3D bioprint cartilage ring constructs with chondrogenic bioink and prevascularized ring
constructs with vasculogenic bioink using the individual cell-only bioprinting technology, and (3) engineer
prevascularized and epithelized tracheal tissue with chondrogenic and vasculogenic bioinks using the individual
cell-only bioprinting technology. As an exploratory aim, the capacity of the engineered tracheas to restore airway
functionality will be evaluated in an animal defect model. This work ultimately seeks to utilize a facile and flexible
individual cell-only bioink 3D printing platform to engineer a patient-specific replacement trachea that provides
requisite physiologic and mechanical properties for replacement in those that are affected by long-segment
tracheal stenosis. The inherent flexibility of this individual cell-only 3D printing platform to create complex
structures composed of multiple spatially distinct tissue types can be leveraged to develop other multi-tissue
organs.

Public health relevance
Narrative Respiratory problems are a common cause pain, disability and death of US military veterans and soldiers. Since there are no long-term effective treatments to restore airway function when long segments of the trachea are damaged, we propose to engineer a functional neotrachea using autologously sourced individual cell-only bioinks within a three-dimensional printing platform. The engineered neotrachea will be comprised of cartilaginous, vascular and epithelial tissue that will provide mechanical rigidity, the ability to anastomosis with the native vasculature, and protection from outside exposure, respectively, to support airway function. This new strategy to create functional trachea tissue through a scaffold-free cell printing platform may represent a therapeutic advance to treat veterans and soldiers suffering from airway damage.